Enabling Strategies for Growing Collagenous Tissues

[unreadable] DESCRIPTION (provided by applicant): [unreadable] [unreadable] Connective soft tissues, which include skin, fascia, ligament, tendon, blood vessel, etc, rely upon extracellular matrix to provide the bulk of their mechanical properties. In the body, soft connective tissues must withstand the physical forces that are created by physiological processes and by movement in every day life. Collagenous extracellular matrix provides tensile load bearing properties in all soft connective tissues. In some connective tissues, such as skin and blood vessel, extracellular elastin also contributes recoil in response to tensile strain. If we are to engineer functional connective tissues "from scratch", then it is crucial to understand the deposition and remodeling of extracellular matrix proteins, particularly collagen and elastin. Only by fundamentally understanding the processes that govern matrix formation in regenerative medicine can we successfully design functional connective tissues. While multiple investigators have successfully engineered individual tissues with good mechanical properties, we currently possess no tools for a more global understanding of the process of matrix formation. Mathematical models for matrix synthesis and mechanics, and bioreactor systems that allow imaging of matrix deposition are not readily at hand. Indeed, the focus of the NIH PAR 06-504, "Enabling Technologies for Tissue Engineering and Regenerative Medicine", is on the development of just such tools. In this application, we will exploit and develop novel mathematical models, bioreactors, and non- invasive imaging systems to predict, track and quantify the deposition of extracellular matrix in vitro. The goal of this work is to generate novel, yet translatable, tools for understanding extracellular matrix formation. These tools, in turn, will fundamentally advance our abilities to grow connective tissues for regenerative medicine. The imaging, bioreactor and modeling approaches developed in this application will be directly translatable to other laboratories that are working in these areas. In order to ensure broad applicability of the tools created herein, we will use mathematical models, novel bioreactors and imaging systems to study matrix deposition in two commonly used tissue engineering systems: planar hydrogel scaffolds, and tubular mesh scaffolds. Planar hydrogel scaffolds will be used as a model of sheet-like connective tissues, such as fascia and ligament. Tubular mesh scaffolds will be used as a model of tubular connective tissues, such as blood vessels. In both of these experimental systems, we will apply novel bioreactors and non-invasive microscopy techniques, and will couple experimental design and observations with computational models of extracellular matrix formation, in order to advance our understanding of the deposition and remodeling of matrix proteins. The purpose of these studies is to develop broad, generalizable tools for use in tissue engineering and regenerative medicine. While methods for growing tissues have advanced, our abilities to predict how tissues will develop, and our abilities to monitor tissue growth, remain very limited. In this application, we will develop sophisticated mathematical models, non-invasive imaging techniques, and novel bioreactors that will allow us to precisely control and predict how new tissues will grow. (End of Abstract) [unreadable] [unreadable] [unreadable]